Membrane reconstitution approach for the investigation of lipid peroxidation mechanisms and its pathological effects

Project Summary
This project aims to determine the chemical mechanisms of lipid peroxidation in membranes. The accumulation
of lipid peroxides on cellular membranes is a process that accompanies aging, as well as a host of age-related
diseases, such as cancer, Alzheimer’s disease, stroke, and heart diseases. More recently, it was discovered that
lipid peroxidation leads to a programmed cell death, called ferroptosis, which may provide the connection
between lipid peroxidation and diseases. Despite their fundamental role in aging and health, the mechanistic
nature of lipid peroxidation and its connection to the diseased state in cells remain elusive. This may be because
lipid peroxidation studies are usually carried out in live cell context, where quantitative measurements are
difficult, or with lipids in organic solvents, where it lacks biological relevance. There are two important questions
with respect to lipid peroxidation and ferroptosis: one is which of the two fundamentally different pathways,
enzymatic peroxidation or non-enzymatic autoxidation involving free iron, is responsible for the membrane lipid
peroxidation in cells. The other is how lipid peroxidation leads to ferroptosis and other adverse cellular outcomes.
To investigate these problems, we will develop a membrane-based assay for quantitative measurement of lipid
peroxidation. By using surface-selective fluorescence microscopy to detect the generation of lipid peroxides, we
will elucidate chemical mechanism of lipid peroxidation in the membrane context. We hypothesize that both the
enzymatic and non-enzymatic pathways are important in efficient lipid peroxidation, as they play different roles
in the process: the enzyme, lipoxygenase, initiates peroxidation with the selective binding for lipid substrates.
Then, after a critical amount of lipids have been oxidized, membrane structural disintegration allows iron-
catalyzed propagation of further peroxidation. We will test this hypothesis by directly measuring the rate of lipid
peroxidation in membranes under enzyme-driven and autoxidative conditions. We further hypothesize that lipid
peroxidation inflicts a chemical damage to membrane proteins, and the impairment of their function leads to
cellular death. To test this hypothesis, we will evaluate the structural and functional impact of lipid peroxidation
on Ras, an important signaling protein that is known to be sensitive to oxidative damage. The results of this study
will provide a better understanding of lipid peroxidation, which underlies many age-related health concerns and
therapeutic strategies to combat them.

Public health relevance
Project Narrative Membrane lipid peroxidation is a type of oxidative damage that accompanies senescence-associated changes in cells and related diseases, as well as the hallmark of ferroptosis, a type of cell death. However, it is unclear which chemical reactions drive the mass peroxidation of lipids confined in membranes, or it leads to the diseased state or ferroptosis. This project seeks to answer these questions by developing a fluorescence-based assay to measure the kinetics of lipid peroxidation in supported lipid bilayers.